Multi-Omic Analysis of BMP-Insulin Signaling Crosstalk in Lipid Metabolism during Aging

Project Summary
The incidence of obesity and overweight health stress in the United States and elsewhere has elevated
dramatically in the last 50 years, increasing the risk of age-related health disorders including cardiovascular
disease, cancer, and Alzheimer’s disease. A comprehensive understanding of the underlying biological
mechanisms that drive lipid storage and lipid mobilization is a critical piece in facing this challenge. The
nematode Caenorhabditis elegans has emerged as a powerful model system in which to identify mechanisms
of lipid homeostasis. We identified TGFβ/BMP signaling as one such mechanism. We focused on the
TGFβ/BMP-related ligand DBL-1, discovering that DBL-1/BMP is required for normal lipid accumulation in the
animal. DBL-1/BMP promotes lipid storage in part by downregulation of insulin/IGF-1-like signaling (IIS), which
is mediated by the DAF-2 insulin receptor and the DAF-16 FoxO transcription factor. Moreover, DBL-1/BMP
signaling modulates outcomes in a C. elegans model of Alzheimer’s disease, which may be related to its
functions in lipid metabolism. We now seek to identify the mechanisms of crosstalk and the downstream
effectors of BMP and IIS in lipid metabolism during aging using a multi-Omic approach. We hypothesize that
DBL-1/BMP signaling through its Smad transcription factors crosstalks with IIS via DAF-16/FoxO to
regulate lipid metabolism, fat accumulation, and adult physiology. To test this hypothesis, we will address
the following specific aims: (1) Determine the transcriptional network mediating BMP and IIS regulation of
lipid metabolism; (2) Identify how DAF-16/FoxO genome occupancy is influenced by DBL-1/BMP
signaling; and (3) Determine the metabolic profiles dictated by DBL-1/BMP and IIS activity. Taken
together, these experiments, using next-generation Omics methodologies, will characterize the complete
picture of transcriptional and lipid dynamics directed by BMP and IIS signaling (and their cross-regulatory
interaction) in an intact organism during aging. This integration of approaches and fields using the C. elegans
model is not easily applied in other systems, particularly in the context of whole-organism aging. These studies
will also generate detailed transcriptomes and metabolomes needed for future hypothesis-driven research.
Due to the high degree of conservation of these signaling pathways, we anticipate valuable insight into
universal mechanistic principles regulating lipid homeostasis and its contribution to age-related illnesses
including metabolic syndrome and Alzheimer’s disease.

Public health relevance
Project Narrative Metabolic dysfunction is a major risk factor for age-related physiological decline, including cardiovascular disease, cancer, and Alzheimer’s disease. Cell signaling pathways coordinate fat storage and mobilization across tissues, but the mechanisms by which they interact and how they mediate their effects requires further elucidation. In this project, we will employ next- generation technologies in an animal model organism to uncover signaling mechanisms that regulate fat metabolism and storage during aging.